Elucidating HIV-1 nuclear trafficking to integration sites

Project Summary
The nuclear entry and transport of HIV-1 to genes for viral (v)DNA integration is determined by viral capsid and
its interaction with the host cellular polyadenylation specific factor CPSF61-3. In the absence of CPSF6
interactions, HIV-1 remains tethered to nuclear pore complexes (NPCs) and integrates outside of genes in lamin
associated genomic domains or LADs3, 4. We have made a seminal discovery2 that CPSF6 interactions drive
HIV-1 replication complexes to accumulate in phase-separated membraneless compartments called nuclear
speckles, in multiple cell-types including primary CD4+ T-cells and macrophages. Notably, nuclear speckles are
formed at sites of transcription and are known to sequester actively transcribing genes5. As such our finding
indicated that the speckle associated genomic domains or SPADs are the primary targets for HIV-1 vDNA
integration. The scientific premise of this proposal is to delineate the mechanisms of how? HIV-1 navigates the
nucleoplasm to reach speckles and integrate into SPADs, a key step in viral replication that remains under-
explored and poorly understood. We hypothesize that the intrinsically disordered low-complexity regions (LCRs)6
and mixed charged RSLD-domains of CPSF6 cooperatively recruit host-factors including nuclear filaments to
capsids for its release into- and transport to nuclear speckle compartments for integration. We will use novel
technologies developed in our lab and, (1) Determine a role for CPSF6-RSLD domain phase-separation in
releasing HIV-1 from NPCs, and in recruiting new host-proteins including speckles for virus nuclear transport,
(2) apply live-cell imaging to visualize HIV-1 nuclear co-trafficking with CPSF6, nuclear actin and nuclear
speckles and determine the contribution of individual CPSF6 LCRs and RSLD domains to this process, and (3)
determine the role of nuclear speckles, and proximal genomic architecture in biasing vDNA integration into
genes. We expect these studies to provide key mechanistic insights into CPSF6-capsid interactions that mediate
nuclear HIV-1 trafficking to integration sites, identify novel SPADs that respond to virus infection and highlight its
implication on global genome architecture, including virus-cell biology.

Public health relevance
Project Narrative HIV-1 infection establishes a stable provirus in the human genome through the process of integration of its viral DNA into actively transcribing genes. The mechanisms of how HIV-1 finds genes for its integration remain unclear. This project will use cutting-edge imaging, integration site mapping and genomics approach to uncover HIV-1 transport mechanisms in the nucleus towards its integration sites, and advance our understanding of virus cell biology, which is of high public health significance.